Generation of DNA memory by bacterial CRISPR-Cas9 systems

Project Summary
Prokaryotic horizontal gene transfer (HGT) underlines the spread of antibiotic resistance and pathogenic traits.
The battle against antibiotic resistance must be fought on multiple fronts, including the understanding of natural
barriers that microbes use to restrict HGT. Most bacteria rely on CRISPR-Cas to establish adaptive immunity
against invasive elements. DNA from these invaders’ genome can be captured and stored as immunological
memories termed spacers, at the CRISPR loci. Small, antisense RNAs produced from CRISPR (crRNAs) will
guide Cas enzymes to destroy invaders with a matching target. In the past decade, much progress has been
made in understanding the CRISPR interference enzymes and their applications in genetic engineering.
However, how microbes acquire their CRISPR memories remains poorly understood.
In this proposal, we aim to uncover the molecular basis for CRISPR memorization (i.e. spacer adaptation). We
use the gram-negative pathogen Neisseria meningitidis (Nme) as a model organism, due to of its clinical
importance and tractable genetics. Current knowledge about spacer adaptation mostly comes from studies of
the type I CRISPR native to E. coli; products of its conserved cas1-cas2 integrase genes can create functional
memories independently of the interference enzymes. Our recent preliminary
findings
suggest that the type II
CRISPR of N. meningitidis creates memory by a distinct mechanism. The interference enzyme, NmeCas9 and
its tracrRNA and crRNA partners, play key but non-conventional roles in the acquisition of functional spacers.
We use molecular genetic, genomic and biochemical approaches to address fundamental questions, including:
What are the molecular roles of Cas9 and the CRISPR-encoded tracrRNA in spacer acquisition? What are the
rules governing memory DNA selection? How does Cas9/tracr cooperate with the Cas1-2 integrase? And
finally, how would the anti-CRISPR proteins affect the memorization process?
This administrative equipment supplement request will allow access to ddPCR instrument, which enables high
throughput and sensitive quantification of nucleic acids. This is essential to decipher CRISPR immunization
beyond DNA transformation, in the context of filamentous phage infection. The impact of research supported
by the parent grant will therefore be greatly enhanced. Collectively, the proposed research will illuminate the
interplay between pathogenic bacteria, their CRISPR systems, and different horizontal gene transfer routes.

Public health relevance
Project Narrative The prokaryotic CRISPR-Cas immune systems counteract parasitic genetic elements and have also provided a set of eukaryotic gene-editing tools that revolutionized the study and treatment of human genetic disease. In this proposal, we will uncover the molecule basis for CRISPR-Cas9 immune memory formation. This work will substantially advance our understanding of CRISPR biology and help expand the spectrum of CRISPR-based technologies to benefit human health. This administrative equipment supplement request will allow access to ddPCR instrument, which enables high throughput and sensitive quantification of nucleic acids. This is essential to decipher the interplay between CRISPR immunization and filamentous phage life cycle. Consequently, the impact of research supported by the parent grant will be greatly enhanced.